California Animal Food Regulatory Program Standards Maintenance

PROJECT SUMMARY/ABSTRACT (OVERALL)
The California Department of Food and Agriculture (CDFA) works to ensure the safety
of the food and feed supply through effective prevention, intervention, and response
programs. Within CDFA, the Commercial Feed Regulatory Program (CFRP) is
responsible for the enforcement of California state law and regulations pertaining to the
manufacturing, distribution and labeling of commercial livestock feed while preventing
adulterated feed from being consumed by livestock.
The overall goal of this proposal is to advance the development of a nationally
integrated food safety system through participation in the Animal Food Regulatory
Program Standards (AFRPS) Maintenance Phase Track. CFRP has been an active
participant in the AFRPS since its inception in 2015 and was officially certified as fully
implemented in February 2024. Participation in the AFRPS has enabled CFRP to
strengthen its already robust inspection and enforcement programs, industry education
and training programs, and feed emergency response programs, while also
implementing program assessment and accountability measures.
This project will enable CFRP to continue this successful collaboration with the US Food
and Drug Administration (FDA) and other state animal food regulatory programs and
meaningfully contribute to the continuous improvement of the AFRPS, including
participation in national meetings, providing sampling and follow-up support for the
Laboratory Flexible Funding Model (LFFM) agreement, and maintenance of a state
auditing program that meets SMG-8076 audit requirements.
Long-term objectives include strengthened information sharing and interagency
collaboration and increased high-quality comprehensive inspections/investigations to
reduce the incidence of animal feed contamination and associated foodborne illness.

Public health relevance
PROJECT NARRATIVE (OVERALL) The goal of the proposed project is to support the California Department of Food and Agriculture (CDFA) Commercial Feed Regulatory Program (CFRP) in maintaining full implementation of the Animal Food Regulatory Program Standards (AFRPS). This project will enable CFRP to continue its successful collaboration with the US Food and Drug Administration (FDA) and other state animal food regulatory programs, contribute to the continuous improvement of the AFRPS, conduct follow-up activities in response to samples identified as part of the Laboratory Flexible Funding Model (LFFM) cooperative agreement, and maintain SMG-8076 audit requirements. These activities reinforce the overall mission of protecting food safety and public health by building CFRP's capacity to conduct comprehensive animal food inspections, prevent and respond to violations and emergencies, align state activities with national standards, and strengthen interagency communications, thereby supporting a national, fully integrated food safety system.